Dysfunctional neurovascular interactions and neuroprogression in early-course psychosis: ex vivo investigation with patient-derived stem cells

Biomarker studies in early course psychosis (ECP) have repeatedly observed four independent phenomena.
First, the presence of decline in symptoms, cognition and functioning that begins in ECP with a neuroprogressive
course in ~40% of individuals. Second, the evidence of blood brain barrier (BBB) dysfunction in neuroimaging,
postmortem, blood and CSF studies in ~40% of individuals with psychotic disorders. Third postmortem,
neuroimaging, genetic and cellular studies show differences in synaptic biology that contribute to neurocircuit
dysfunction in psychotic disorders. Fourth, our studies using induced pluripotent stem cell (iPSC)-derived brain
microvascular endothelial cells (BMECs) show that individuals with psychotic disorders have intrinsic deficits in
BMEC barrier properties and that the BMEC secretome modulates dendrite morphology in human iPSC-derived
cortical neurons. These findings suggest that BBB deficits may play a role in neuroprogression in ECP. While
many of these findings have been replicated, they have not been mechanistically linked with each other.
Developing assays using iPSC-derived BMECs and neurons to measure ex vivo BBB function and neuronal
biology respectively, hold unprecedented opportunities to identify molecular, cellular, and circuit-level changes
related to neuroprogression in ECP. Yet, clinical and iPSC-derived cellular studies to date have been performed
separately without demonstrating a mechanistic relationship between neuroprogression and cellular/molecular
factors of ECP. Therefore, there is a critical need to unite clinical trajectories and iPSC-derived BMEC/neuron
studies in the same individuals to mechanistically link neuroprogression to ex vivo BBB dysfunction in ECP. The
overall objectives for this project are to identify cellular-molecular substrates underlying neuroprogression in ECP
and develop reliable biomarkers that can be leveraged for novel therapeutics. Our central hypothesis is that
intrinsic deficits in iPSC-derived BMECs will correlate with the presence of neuroprogression in ECP and
systematic interrogation of these BMECs will identify mechanisms contributing to this neuroprogression. We aim
to develop a integrated translational neuroscience experimental framework by leveraging complementary clinical
and ex vivo studies of BBB function in the same cohort of ECP individuals to delineate mechanistic links between
neuroprogression and BBB function in ECP. Here, we aim to test the following hypotheses: 1) ex vivo BBB
dysfunction is linked to neuroprogression in ECP, 2) there is a dual cellular hit with intrinsic neuronal deficits in
ECP that are exacerbated by BMEC dysfunction, and 3) that TNF-MMP1 signaling and Rho-associated kinase
regulation of CLDN5 phosphorylation and localization in BMECs underlie BBB dysfunction in ECP. The proposed
research is innovative in combining longitudinal clinical (i.e., psychosis symptoms, cognition, and functioning)
assessments and ex vivo BBB function studies in the same patients to better understand the cellular/molecular
deficits associated with neuroprogression in ECP. The proposed research is significant because it will contribute
meaningfully to the biological mechanisms underlying neuroprogression in ECP.

Public health relevance
The proposed research is relevant to public health because significant cognitive decline and neuroprogression often occur following psychosis onset, but the mechanisms underlying these changes remain elusive. This innovative collaborative project will combine longitudinal cognitive assessments and ex vivo stem cell-based models to understand the role of the blood brain barrier in neuroprogression in early course psychosis.